Improving Stroke Outcomes for African Americans

Stroke is the 3rd leading cause of death and one of the leading causes of adult long-term disability in the US, with high impact for African Americans. Since 90% of stroke survivors are functionally impaired, improving stroke outcomes is a major public health issue. Agencies such as CMS and the Joint Commission have implemented performance programs including quality indicators (QIs) which would ideally be selected based on impact on stroke-related outcomes, but such evidence is currently scant. The Institute of Medicine has stated

Public health relevance
Stroke outcomes are worse for African Americans than for others in the US. This study will examine medical care provided to 1200 individuals who suffered an acute ischemic stroke to determine which types of care provided during their hospitalization lead to the best outcomes further down the road, and how to optimize outcomes for people who already had diabetes or chronic kidney disease at the time of their stroke.